Contribution of Urinary Phosphate to CKD Progression

Project Summary/Abstract
Chronic kidney disease (CKD) affects approximately 15% of the U.S. population and is a leading cause of
morbidity and mortality due to an exceedingly high rate of cardiovascular, skeletal, hematologic, immune, and
cognitive abnormalities that accompany this disorder. There are limited therapies available to slow CKD
progression, underscoring the importance of research aimed at developing novel interventions for this
condition. When kidney function is reduced urinary phosphate excretion increases to maintain normal serum
phosphorus balance. This is driven by two phosphaturic hormones, fibroblast growth factor 23 (FGF23) and
parathyroid hormone (PTH). Elevated levels of these hormones is associated with more rapid CKD
progression. Additionally, mineral deposition is frequently observed in CKD kidneys, regardless of clinical
context, and may be a stimulus for chronic inflammation that promotes CKD progression. We hypothesize that
high concentrations of urinary phosphate contribute to CKD progression by promoting phosphate-based
nanocrystal formation, tubular epithelial cell injury, and interstitial inflammation which could be prevented by
reducing urinary phosphate excretion or enhancing urinary phosphate solubility.
Studies in this proposal aim to define the role of phosphaturia in mechanisms of CKD progression. By
analysis of a mouse model of chronic phosphaturia and human kidney biopsy samples, the following specific
research aims will be accomplished: (1) define how chronic phosphaturia impacts CKD progression in mice,
(2) determine if enhancing tubular phosphate solubility with phosphorylated ASARM peptides prevents CKD
progression, and (3) define the prevalence of kidney mineral deposition in a cohort of human kidney allografts
and determine clinical risk factors associated with increased mineral deposition. Data from these studies will
provide details on the pathophysiology of chronic phosphaturia in CKD and support the development of future
innovative therapies to slow CKD progression.
These research aims will be completed within a comprehensive, five-year career development plan that is
overseen by a robust, experienced mentorship team. This proposal includes training and didactics that will
further develop the candidate’s knowledge of research techniques and biostatistics important for translating
basic science findings to innovative clinical applications. The candidate is currently an assistant professor in
the Division of Nephrology and Hypertension at the University of Kansas Medical Center (KUMC) and has 75%
protected time for research, independent laboratory and office space, and regular interaction with a
multidisciplinary, collaborative group of researchers in the Jared Grantham Kidney Institute at KUMC.
Completion of this proposal will build on the candidate’s extensive research background and provide a strong
foundation for the candidate’s long-term goal of establishing a successful, independent career aimed at
developing novel therapies to slow CKD progression.

Public health relevance
Project Narrative Chronic kidney disease (CKD) affects approximately 15% of the U.S. population and is a leading cause of morbidity and mortality due to an exceedingly high rate of cardiovascular, skeletal, hematologic, immune, and cognitive abnormalities that accompany this disorder. Elevated levels of hormones that increase urinary phosphate excretion are associated with more rapid CKD progression and adverse clinical outcomes, but the mechanism for this association is undefined. The proposed studies will define the role of phosphaturia in mechanisms of CKD progression and determine the therapeutic effect of increasing urinary phosphate solubility, thus providing compelling data to support future development of innovative therapies to slow CKD progression.